CYSTIC FIBROSIS GENE THERAPY--IN VIVO SAFETY AND EFFICACY IN NASAL EPITHELIUM

Assess safety and efficacy of the cystic fibrosis transmembrane conductance regulation (CFTR) gene construct applied to airway epithelium.